Core D Metabolic Phenotypes of Aging

CORE D: METABOLIC PHENOTYPES OF AGING – SUMMARY
Molecular genetic approaches have led to tremendous advances in the study of the basic biology of aging,
shedding light on the causes and consequences of senescence. But there remains a significant gap between
our ability to identify genetic and experimental perturbations that extend lifespan, and our understanding of the
mechanisms by which these perturbations extend lifespan. Detailed metabolic information, obtained through the
integration of metabolomics and mitochondrial metabolism interrogations, offers a powerful approach to close
this gap. The metabolome measures the concentration of hundreds to many thousands of small molecules that
make up the structural and functional building blocks of all living organisms and play an important role in not
only metabolism, but also intra and inter-cellular signaling, epigenetic regulation, and protein function. Aim 1 of
Core D provides a broad range of metabolite profiling methods by closely liaising with the Northwest
Metabolomics Research Center. The available advanced mass spectrometry and NMR platforms provide a
broad-based approach for targeted, global assays of aqueous and lipid metabolites and metabolic flux
analyses for aging-related biomarker discovery and for basic systems biology research. Aim 2 provides
analytical workflows for rigorous statistical analyses of aging related pathways, metabolomic clock and
biomarker discovery. Core users will receive detailed training by experts on the use of multivariate statistical
methods as well as metabolic pathway analysis tools to allow them to quickly access the superb capabilities in
metabolomics. Aim 3 offers customizable assays of mitochondrial oxidative phosphorylation, including
respiration, membrane potential, and oxidant production. These services are focused on complementing the
metabolomic assays of Core D and the other Resource Cores of the UW NSC to provide a simple integrated
resource to incorporate quantitative measures of mitochondrial function with multi-omics and invertebrate
model technologies provided by the UW NSC. The resources provided by Core D to quantify changes in
metabolic and signaling roles of metabolites in aging support the emphasis of the UW NSC on cross core
collaboration for highly integrated multi-omics analyses to support impactful research into the biology of aging.